Emerging Infectious Diseases Research Centers Coordination Center (EIDRC CC)

PROJECT SUMMARY/ABSTRACT
Emerging and re-emerging infectious disease (EID) outbreaks that are occurring with increasing frequency in
high-risk areas in South/Central America, West/Central Africa, and Southeast Asia are a threat to the United
States. Documented gaps in research infrastructure limit the capacity to rapidly respond to these outbreaks.
To address this challenge, the National Institute of Allergy and Infectious Diseases (NIAID) is establishing
the Emerging Infectious Disease Research Centers Network (EIDRC-Net) to improve knowledge of EIDs;
leverage existing NIAID international efforts; and develop the capacity to mount effective, flexible, and rapid
outbreak research responses. RTI International and Duke University propose to establish the EIDRC
Coordination Center (EIDRC CC). The RTI-Duke CC will support the EIDRC-Net, which will comprise the
EIDRCs, research sites, the CC, and NIAID by realizing the following aims: (1) enhance EIDRC coordination
and collaboration by providing administrative, communications, logistical, and operational support; (2)
amplify NIAID's capabilities and reach by coordinating and supporting a sustainable, scalable, and adaptable
research infrastructure to optimize resources and knowledge sharing during inter-outbreak periods and to
respond rapidly and effectively during outbreaks; (3) ensure quality and consistency of study data by using
rigorous data and specimen management systems with built-in data quality assurance; (4) ensure quality of
biospecimens, assays, and reagents through harmonization of standard operating procedures across
EIDRC-Net sites and ongoing audit of cross-network procedures; and (5) develop the next generation of
investigators and in-country scientists by establishing a pilot research program that identifies, funds, and
mentors high-quality EIDRC applicants. By successfully accomplishing our five specific aims, the RTI-Duke
team will shift the outbreak research response paradigm by establishing scalable systems, processes, and
resources that not only provide the necessary infrastructure to facilitate EIDRC-Net performance and carry
out CC core functions during inter-outbreak periods, but also can be enhanced and expanded to bolster CC
research surge response activities during outbreaks. The EIDRC CC team will be co-led by multiple Principal
Investigators Donald Brambilla, PhD (RTI), a biostatistician with advanced training in biology and an
experienced CC leader, and Michael Anthony (Tony) Moody, MD (Duke), a pediatric infectious disease
specialist and Chief Medical Officer of the Duke Human Vaccine Institute. Together they bring extensive
scientific expertise, leadership, administrative experience, and international research expertise, including in
geographic locations most relevant to the study of EIDs. This partnership also leverages the operational
efficiency of RTI, a large nonprofit research organization with regional and project offices in over 75
countries, with the scientific rigor of Duke University, a premier university known for its cutting-edge medical
research and home to a state-of-the-art, NIAID-funded Regional Biocontainment Laboratory.

Public health relevance
PROJECT NARRATIVE Emerging and re-emerging infectious diseases are occurring with increasing frequency and are a threat to human health in the United States and worldwide. To improve knowledge of these diseases and develop the infrastructure to conduct infectious disease research, National Institute of Allergy and Infectious Diseases (NIAID) has formed the Emerging Infectious Diseases Research Centers Network (EIDRC-Net). RTI International and Duke University propose to jointly establish the EIDRC-Net Coordination Center to provide overall Network coordination and communication and to build a research infrastructure to help NIAID respond rapidly to infectious disease outbreaks when they occur.